Models and methods for automatically measuring disease body-wide and staging disease via FDG-PET/CT in Lymphoma

Quantitative Radiology holds great promise to transform our ability to diagnose, monitor, stage, prognosticate,
and detect diseases as well as to plan and guide patient therapeutic interventions. However, the process of
locating and delineating anatomic organs and pathologic regions in medical images, known as image
segmentation, at a high level of automation has remained a major hurdle to these advances. Most
developments on image segmentation have focused on a specific organ or a small group of objects in a
specific body region. A new method or a major adaptation of an existing method is engineered when any of
these parameters changed. Such an approach is not sustainable and becomes a stumbling block when dealing
with whole-body systemic diseases where body-wide image analytics is required. A critical advance is needed
in this field to overcome two main challenges: (1) Although prior information about normal anatomy is deemed
vital for image segmentation and analysis, its creation and utilization body-wide on a massive scale have not
been attempted and are sorely lacking. (2) Techniques to employ such information and methods for body-wide
disease quantification at high levels of automation do not exist. The overarching goal
is to overcome these
challenges by developing a body-wide and generalizable anatomy-guided deep learning image segmentation
methodology
and demonstrate its application in the study of patients with diffuse large B cell lymphoma
(DLBCL) for which PET-based staging and response assessment are of paramount importance.
The project has three specific aims. Aim1: To develop a family of body-wide anatomy models representing the
entire human adult age spectrum.
Existing FDG PET/CT scans of 600 patients from two institutions (Penn and
New York Proton Center) covering 10 age groups will be utilized to build anatomy models involving 50 organs
and 50 lymph node zones in the extended body torso including neck, thorax, abdomen, and pelvis.
A family of
40 anatomy models representing the 4 body regions and 10 age groups will be created from roughly 60,000 3D
object samples. Aim2: To develop, implement, and validate a methodology for localizing objects and to
quantify disease without explicitly delineating organs and lesions. Gender- and age-specific anatomy models
will be utilized for automatically locating the above 100 objects in any given patient PET/CT image and to
quantify disease in each body region, organ, and lymph node zone. The methods will be tested on 400 PET/CT
images of DLBCL patients. Aim3: To develop and validate an automated method of DLBCL disease staging
and prognosis. The disease quantity information will be utilized to develop automated staging and outcome
prediction algorithms which will be tested on the above 400 cases in comparison to current clinical methods.
Two key outcomes of this project will be: an unprecedented well-curated database of body-wide images,
segmented objects, and family of models; and a validated methodology for automatic body-wide disease
quantification and disease staging in DLBCL.

Public health relevance
Most current methods for the fundamental image analysis task of object segmentation have focused on a small group of objects and were designed to operate on a specific imaging modality - an approach that is not sustainable and becomes a stumbling block when dealing with whole-body systemic diseases where body- wide image analysis is called for. The main goal of this project is to develop a body-wide and generalizable image segmentation and analytics methodology that is based on creating a comprehensive family of body-wide anatomic models covering the entire adult human age spectrum and performing disease quantification without explicitly delineating objects. The project will apply this methodology to the study of patients with diffuse large B cell lymphoma (DLBCL), a common subtype of lymphoma, for which PET-based staging and response assessment/ prediction is of paramount importance clinically.